Distinct contributions of converging neural pathways to auditory learning

PROJECT SUMMARY/ABSTRACT
Effective interpretation of sensory stimuli relies on the ability to discriminate stimulus features
and link them to appropriate behavioral responses depending on past experience. Much remains
unknown, however, about the roles that different neural pathways play in representing and learning
these associations, and in particular, how information is distributed and combined among different
pathways during learning and execution of behavior. As a step toward addressing the long-term goal of
understanding how the nervous system flexibly links sensory stimuli to actions, this research will focus
on auditory decision making to study the contributions of the multiple auditory pathways that target
the striatum, the main input stage of the basal ganglia and a key structure in the regulation of motor
behavior. Specifically, the project will focus on the flow of information from the auditory thalamus
as well as primary and non-primary areas of the auditory cortex to the posterior tail of the striatum.
The central hypothesis is that the various auditory cortical and thalamic pathways to the striatum all
play distinct roles during learning and execution of sound-driven decisions. This work will consist of
developing theoretical models of sound representation and learning in the multiple auditory pathways
converging on the striatum, as well as carrying out experiments in mice trained to perform acoustic
discrimination tasks in order to test and refine these models. These experiments will take advantage
of novel techniques for reversible manipulation of specific neural pathways while monitoring large
numbers of neurons simultaneously during behavior. The project is organized in three aims. The first
aim is to determine the conditions in which auditory cortico-striatal and thalamo-striatal pathways play
distinct roles during performance of sound-action association tasks. The second aim is to determine the
roles of auditory cortical vs. thalamic pathways to the striatum during learning of these tasks. The third
aim is to identify the acoustic features of natural sounds conveyed by distinct auditory cortical fields to
the striatum. Together, these studies will reveal the computational roles played by converging neural
pathways in acquiring and executing learned behaviors.

Public health relevance
NARRATIVE While much is known about how neurons respond to sensory stimuli, much less is known about the neural pathways and mechanisms linking specific sensory features to actions that yield positive outcomes. Our goal is to dissect the contributions of distinct neural pathways providing input to striatum—a key structure in the regulation of motor behavior—during learning and execution of sound-driven choices. This work will shed light on the neural-circuit mechanisms linking sounds to actions and, more broadly, on the basic computational principles governing how distinct streams of information from converging neural pathways are combined to facilitate learning, both in healthy and diseased contexts.